Program support for developing small area estimates for selected tobacco-related outcomes using data from the TUS-CPS

The purpose of this agreement is to support part of the time of a mathematical statistician in the Census Bureau’s Center for Statistical Research and Methodology (CSRM) who can provide programming support to continue to do the modeling work for selected tobacco-related outcomes using data from TUS-CPS and help coordinate project meetings. This assistance will help streamline the progress on this project, especially because of the confidential nature of the data required